UC Davis Clinical and Translational Science Center

The University of California, Davis (UC Davis) Clinical and Translational Science Center (CTSC) will build on a 14-year track record serving as the central nidus for translational research in inland Northern California. We have created a cadre of translational investigators, highly competent research workforce, and efficient regulatory processes. The CTSC is at the center of UC Davis translational research and is a robust convener and facilitator of collaborations across a wide spectrum of disciplines. Embracing a flexible and versatile culture aimed at research facilitation, resource sharing, and partnerships, the CTSC is responsive to investigators, trainees, scholars, faculty, and our broader community partners. The program works closely with departments and centers to recruit, support, and retain research teams, particularly those addressing special populations. By fostering trainee and scholar success at all career stages to ensure an upward trajectory, the UC Davis CTSC builds the workforce needed to advance the Clinical and Translational Science Awards (CTSA) goals. The CTSC is viewed as a respected partner fully integrated into the entire UC Davis campus and leadership. The current proposal builds on a rich foundation of achievements including team-science educational and research endeavors, use of digital health technologies to engage communities with less internet-based health services, cross-cutting community partnerships to advance health care access and community-based participatory research, and comprehensive data science training and resource support. Significant areas of strength at UC Davis include our prominent digital health program, community engaged collaborative research, and a comprehensive academic setting where the CTSC is the trusted enabler. Through a far reaching and highly integrated infrastructure, quality focus, and training resources to coalesce healthcare delivery science, the CTSC will promote and advance the Learning Health System. Using all assets developed and the productive relationships established with multiple partners, the CTSC will elevate UC Davis into a next phase of high impact clinical and translational research through the following Specific Aims: (1) Serve as an experienced hub for clinical and translational research; (2) Expand and refine a collaborative and innovative training environment that ensures research of the highest quality; (3) Fully integrate community partners into the translational research enterprise; (4) Efficiently utilize, expand, and leverage informatics and data science resources; and (5) Function as a nexus for the integration of research across the lifespan. To achieve these goals, the experienced and well-integrated CTSC team under the leadership of Ted Wun, MD, will accelerate our strong trajectory for the future with overwhelming support from the institution and guided by a comprehensive oversight structure that fully anchors the CTSC within UC Davis and the CTSA Consortium.

Public health relevance
PROJECT NARRATIVE The UC Davis Clinical and Translational Science Center (CTSC) has established workforce development and infrastructure resources that supports and promotes education and research activities to improve human health. Innovative translational and clinical research findings are disseminated to health professionals, trainees, scholars, and community partners, and function within national collaborative networks to ensure a broad-based information exchange that will lead to improved human health across all age groups. Project Narrative Page 201